The role of neuro-immune interactions in PACAP induced migraine

Project Summary
Migraine headache is the most common neurological disorder and comes with great socioeconomic burden.
Much is still not known about the mediators and receptor subtypes involved in this debilitating disease, but
studies (preclinical and clinical) have shown that neurogenic inflammation as a result of neuropeptide release
may be involved. Animal studies have shown crosstalk between mast cells and meningeal nociceptors is crucial
to the initiation and maintenance of migraine. The mast cell specific GPCR MrgprB2, and its human homologue
MRGPRX2, is known to contribute to neurogenic inflammation in animal models of pain. Previous research
showed that activating MrgprB2 causes mast cells to release a broad range of pro-inflammatory cytokines,
contributing to pain pathophysiology. Our lab’s preliminary data reveals MrgprB2 receptors are expressed in the
resident tissue mast cells within the dura, in close proximity to meningeal afferents. We used a non-invasive
dural stimulation migraine model to demonstrate that activation of MrgprB2 by its agonist Compound 48/80
produced facial mechanical hypersensitivity and grimace expressions indicative of migraine-like pain behavior.
The endogenous neuropeptide Pituitary adenylate cyclase-activating peptide-38 (PACAP-38) has been found to
increase in the acute phase of migraine. We found PACAP-38 prompts MrgprB2-dependent mast cell
degranulation in vitro, indicating that PACAP-38 may act on MrgprB2 during migraine. This compelling
preliminary data supports testing our central hypothesis that MrgprB2/MRGPRX2-expressing mast cells play an
important role in the migraine pain pathway, interacting with meningeal afferents and the endogenous peptide
PACAP-38. The current application examines what role MrgprB2, and its human homologue MRGPRX2, may
play in triggering a migraine like pain phenotype, how the endogenous neuropeptide PACAP-38 may interact
with the immune system to induce migraine pain pathology via MrgprB2/MRGPRX2 activation, and whether
MrgprB2/MRGPRX2+ mast cells cause migraine like pain through direct activation of meningeal sensory
neurons. Using state-of the art approaches, the following specific aims will test our hypothesis: Aim 1.
Characterize the contribution of mast cells and their receptor MrgprB2/MRGPRX2 in mouse models of migraine
like pain. Aim 2. Examine MrgprB2/X2 interaction with known migraine-inducing endogenous peptide PACAP-
38. Aim 3. Examine the interaction between MrgprB2+/MRGPRX2+ mast cells and meningeal sensory neurons
in vivo. The proposed research is significant because it will examine the contribution of these mast cell receptors
to the mechanisms underlying migraine pain, expanding our understanding on MrgprB2 and MRGPRX2 and
their role in linking neural and immune systems to migraine-induced pain pathology. Importantly, MrgprB2/X2
may provide a new target to potentially treat migraine.

Public health relevance
Narrative Worldwide, migraine headache is the most common neurological disorder and comes with great socioeconomic burden. Mast cells are a type of immune cell located in the thin covering of the brain, called the meninges, and have long been linked to migraine. In this proposal we plan on examining a receptor family, Mrgpr, specifically expressed on mast cells; and their role in linking neural and immune systems to migraine-induced pain.